Investigating unknown yet essential mechanisms of gene regulation for tick-borne relapsing fever spirochetes.

Project Summary
Relapsing fever (RF) Borrelia are vector-borne pathogens that causes significant morbidity and mortality in low-
and middle-income countries, while we are also observing the emergence of the disease in populated regions of
North America. Pathogenic spirochetes are transmitted by the human body louse and ixodid and argasid ticks.
Since most species of RF Borrelia are transmitted by argasid ticks in the Ornithodoros genus, we developed this
model. Unfortunately, we do not understand the molecular mechanisms driving RF spirochete transmission
leading to an absence of preventative interventions that disrupt the pathogens’ life cycle. While RF- and Lyme
disease-causing spirochetes are in the same family, their biology significantly differs indicating what is known for
one system is not necessarily applicable to the other. One key difference is that populations of RF spirochetes
persistently colonize Ornithodoros midguts and salivary glands. The salivary gland population is essential
because those spirochetes are preadapted for entry into the vertebrate host and are transmitted within seconds
of tick bite. Upon transmission, vector-specific genes are downregulated and the variable major protein (vmp)
locus, which is responsible for antigenic variation and persistent mammalian infection, is upregulated. However,
very little is known regarding which genes are expressed in the tick and vertebrate and the regulatory
mechanisms controlling their expression. We are addressing this through advances in RF spirochete genomics.
We utilized Oxford Nanopore Technology (ONT) to generate plasmid-resolved genomes needed for
comprehensive transcriptional studies. Furthermore, since it is challenging to obtain enough spirochete RNA
from the tick for transcriptional studies, we characterized salivary glands and found that they are highly oxidative.
This allows us to grow the pathogen in in vitro conditions that better mimic the tick environment. We also identified
essential RF Borrelia genes expressed in the tick (bta132 – bta136) and will build on the importance of vmp to
delineate regulatory mechanisms. We hypothesize that RF spirochetes possess unique mechanisms to regulate
genes differentially expressed during the tick-mammalian transmission cycle. In Aim 1, we will utilize the ONT
platform for a comprehensive analysis of RF Borrelia genes and operons that are upregulated in the tick salivary
glands versus murine blood and determine their transcriptional start sites. The objectives are: 1) perform long-
read ONT-Cappable-seq using in vitro grown spirochetes; 2) analyze data and select candidates; and 3) validate
findings in vivo. In Aim 2, we will investigate the regulatory mechanisms of important genes upregulated in the
tick (bta132-bta136) and mammal (vmp locus) through the identification of promotor regions and DNA-binding
proteins. The objectives are: 1) identify promoter sequences; and 2) identify DNA-binding proteins that interact
with promoters of bta132 - bta136 and the vmp expression locus. Our findings will result in the identification of
genes to target for the development of countermeasures against a significant yet neglected pathogen.

Public health relevance
Project Narrative Relapsing fever (RF) is a significant cause of morbidity and perinatal mortality in low- and middle-income countries and is emerging in metropolitan regions in the United States. This project will begin critical investigations in gene expression and regulation that the pathogens utilize as they progress through their tick- mammalian transmission cycle. Generating the transcriptome of RF spirochetes and understanding the mechanisms controlling differential gene regulation will lead to the identification of targets for the development of counter measures to interrupt the transmission cycle of RF spirochetes and prevent disease in humans.